Interface of Mathematical Models and Experimental Biology: Role of the Microvasculature

The purpose of this proposal is to seek support for a travel award program for the American Physiological Society (APS) conference entitled “Interface of Mathematical Models and Experimental Biology: Role of the Microvasculature” scheduled for September 11-14, 2019 and to be held in Scottsdale, AZ. Collaborations between experimental physiologists and theoretical investigators are increasingly recognized as playing an indispensable role in advancing studies of complex physiological systems. The overall goal of the 2019 Interface of Mathematical Models and Experimental Biology: Role of the Microvasculature conference will be to focus on how investigators are integrating mathematical models alongside experimental approaches to understand the roles of microcirculation and hemodynamics in a variety of organs. This goal will be accomplished by presentations in each symposium from expert basic and clinical experimentalists who have included theoretical analyses in their studies and from mathematical modelers who focus on physiological problems that are related to those described by the experimentalists. Microcirculation topics broadly applicable to organ function and dysfunction in general, will include blood flow in microvascular networks, oxygen transport and diffusion, and acute and long-term regulation of blood flow. These and related topics will then be considered in subsequent symposia as they relate specifically to physiological mechanisms in a variety of organs including kidney, heart, brain and retina and in cancer tissue. Speakers will be encouraged to present largely unpublished data in order to promote the interchange of ideas between modelers and experimentalists and to present the current state- of-the-art computational approaches and their innovative, multiscale applications in understanding microcirculation of kidney, heart, brain, retina and other organs and in cancer tissue. Importantly, the conference will promote the interests of early career investigators and trainees in developing new research programs that take advantage of the insights offered by incorporating mathematical modeling into experimental paradigms that impact basic and clinical organ dysfunction. In order to promote the interest of trainees and early career investigators in the field and their participation in the conference, we propose to administer an NIH-funded travel award program for trainees and early career investigators.

Public health relevance
PROJECT NARRATIVE The purpose of this proposal is to seek support for a travel award program for the American Physiological Society (APS) conference entitled "Interface of Mathematical Models and Experimental Biology: Role of the Microvasculature" scheduled for September 11 14, 2019 and to beheld in Scottsdale, AZ. This conference will foster new synergies and collaborations between established and early career life science experimentalists and mathematicians who focus on physiological and pathophysiological studies. It is expected that this effort will enhance our understanding of organ perfusion in health and disease, and thus will improve and accelerate the diagnosis and treatment of clinical disorders both at the present time and for years to come.